Infection Control Measures in Dialysis Facilities after COVID-19: Disparities in Adoption and Impact on Hospitalization and Mortality

PROJECT SUMMARY
The COVID-19 pandemic threatens the health of patients with kidney failure because end-stage kidney
disease (ESKD) is a risk factor for COVID-19 related death. Most patients with kidney failure undergo
hemodialysis treatment in an outpatient dialysis facility three times a week alongside other patients. This
can result in unavoidable patient clustering and an increased risk of viral transmission. Further, patients
with kidney failure often have multiple comorbidities, high baseline rates of mortality, and are more likely to
be black or Hispanic, racial/ethnic minority groups that have been disproportionately impacted by the
pandemic. High hospitalization rates for ESKD patients also demands a health care system that allows
seamless care coordination between the outpatient dialysis facilities and hospitals.
In order to mitigate patients' risk of contracting COVID-19, facilities could implement several precautionary
measures, including reducing the duration of each hemodialysis treatment session, assigning patients to
separate facilities or shifts that specifically accommodate COVID-19 patients, establishing additional
“isolation” stations within a facility, offering training and support for patients receiving home dialysis, and
providing care to nursing home residents in the nursing home as opposed to an outpatient dialysis facility.
Some dialysis facilities have reported implementing these strategies, but systematic national data about
their adoption and association with meaningful patient outcomes are not known.
Using data from the universe of all outpatient dialysis facilities and a census of patients with kidney failure
undergoing dialysis for the period 2018-2022, this project has three aims. First, we estimate the extent to
which COVID-19 spurred the facility-level adoption of infection-control practices, and to examine the
heterogeneity in adoption across facilities. Our working hypothesis is that facilities affiliated with LDOs,
those located in disadvantaged neighborhoods, and those in counties with high infection rates will be more
likely to adopt protective measures in response to the threat of COVID-19. Second, we investigate the
effectiveness of facility-level infection-control responses on COVID-19 related- and all-cause hospitalization
and mortality. Our working hypothesis is that infection control measures resulted in a reduction of infection-
related hospitalizations and mortality, but non-COVID-19 and overall hospitalization and mortality rates
increased. Third, we estimate the extent to which hemodialysis sessions were impacted for dialysis patients
admitted to hospitals in high-COVID-19 counties. Our working hypothesis is that dialysis patients admitted
to hospitals in counties with high COVID-19 infection rates or COVID-19 “hotspots” experience greater
reductions in dialysis sessions. Overall, our study will have a positive impact since dissemination of
information about responses found effective will allow other facilities to adopt them, and reduce COVID-19
transmission in this vulnerable patient population.

Public health relevance
NARRATIVE The COVID-19 pandemic will test the resilience of health care systems to provide necessary, high quality care to patients. In this study, we examine the response of dialysis providers and the effect on patient outcomes for a vulnerable population of kidney failure patients undergoing dialysis.